Treating drug-resistant infections of burn wounds with an optimized antimicrobial peptide

Project Summary/Abstract
Burn wounds result in 400,000 emergency department visits in the U.S. each year. Around 10%
of these patients require hospitalization where they are particularly susceptible to multi-drug
resistant nosocomial (healthcare-associated) infections due to the loss of skin barrier function
and the extended hospital stays, which are often required for wound healing. None of the
currently available treatments meets all the desired properties of a topical antibiotic for burn
wound care. In response to this clinical gap, the long term goal of the proposed project is to
develop a universal antibiotic solution that is effective against all drug-resistant bacteria
commonly found in burn wounds, does not cause new resistance, does not inhibit
wound healing and which can be applied on all skin surfaces without adverse effects.
Gavia BIO, LLC will develop the antimicrobial peptide DGL13K as a novel topical treatment for
burn wound infections. This unique, patented peptide is effective against all tested bacterial
pathogens, including biofilms and drug-resistant strains. DGL13K reduces infection in a human
skin explant model and animal models without causing topical or systemic toxicity. DGL13K
does not inhibit wound healing. Thus, DGL13K meets the desired properties of a topical burn
wound treatment and fills an urgent need that is not met by currently available treatments. The
goal of this Phase I project is to progress the preclinical development of DGL13K by
demonstrating that topical formulations are a safe and effective broad-spectrum treatment for
burn wound infections in vivo. Three specific aims are proposed to reach this goal. Research in
Aim 1 will test additional species, and expand the library of bacteria and drug-resistant strains
that are found in burn wounds and can be treated with DGL13K. Aim 2 will test topical
formulations of DGL13K in a porcine burn wound infection model. The peptide will be tested in a
soluble formulation and a self-assembling hydrogel formulation to determine if DGL13K affects
bacterial load and time to closure for burn wounds in the porcine model. Research in Aim 3A will
determine if mice develop hypersensitivity to DGL13K after repeated wound applications, while
aim 3B will determine if DGL13K is found in circulation after repeated wound applications. The
expected outcome of this work will expand the safety profile for DGL13K by including safety in a
burn wound model in preparation for clinical application of the peptide. Gavia BIO will develop
DGL13K in collaboration with researchers at the University of Minnesota. The initial focus is on
serious burn wounds, which are mainly treated in regional burn centers that present a focused
target market.

Public health relevance
Project Narrative Burn wounds are highly susceptible to infections with drug-resistant bacteria during the extended hospital stays needed for wound healing but current treatments are fraught with problems including bacterial resistance, toxicity and lack of healing. The proposed project will develop a universal antibiotic solution that is effective against all drug-resistant bacteria commonly found in burn wounds, does not cause new resistance, does not inhibit wound healing and which can be applied on all skin surfaces without adverse effects. This meets an urgent clinical need and addresses NIH program goals in development of therapeutics to treat infectious diseases and wound healing.